Physician Subspecialization and the Health and Health Care of Older Americans

PROJECT SUMMARY
Over the past 40 years, specialist physicians have supplanted primary care as the most frequently seen
clinicians for older adults in the US. This shift towards specialty care is driven by advancing medical technology
and increased “subspecialization,” whereby specialist physicians focus on narrower and narrower clinical
areas. Subspecialization has grown markedly: in 1980, the American Board of Medical Specialties had 28
specialty boards, with an additional 28 certified subspecialties. By 2020, 40 specialty boards encompassed 147
separate subspecialties. While subspecialists bring greater clinical expertise, too much subspecialization could
lead to inequitable access, overtreatment, overdiagnosis or fragmentation of care. There is little empirical
evidence on the implications of growing subspecialization for the health of older Americans.
A major obstacle to filling these evidence gaps is the lack of meaningful measures of subspecialization
at the physician level. Existing physician directories, like the one used by Medicare, contain in-depth specialty
data, but are also highly inaccurate. For example, Medicare data identify only 17% of board-certified advanced
heart failure specialists in the US. Other specialties have similar data gaps. To understand how access to
subspecialists influences access to specific advanced treatments and clinical outcomes, it is necessary to
better define the hundreds of types of subspecialty care being provided to patients.
We propose to characterize subspecialization in the US and assess its implications for the health and
health care of older adults. Using comprehensive data from Medicare, we will develop novel methods to
classify physician subspecialists by their observed practice patterns, focusing on 3 key specialties in the care
of older adults (cardiology, medical oncology and general surgery) as “tracer” disciplines to fill evidence gaps in
subspecialty care that can inform policy. Specifically, we will:
1) Use community detection algorithms, a common tool in network science, to identify subspecialists based on
their practice patterns (as measured by services provided, drug treatments, and patient diagnoses).
2) Identify patient, health system and geographic factors associated with subspecialty supply and access.
3) Using quasi-experimental methods, measure the impact of access to subspecialist care on health outcomes
and utilization in the three key specialties.
These Aims will provide novel evidence to guide health policy, including improved methods to
accurately measure subspecialist supply, guide health insurers and policymakers for applications such as
determining adequacy of specialist coverage in insurance design (e.g., Medicare Advantage), identify
populations with shortages in subspecialist access, and guide telemedicine development. Without this
evidence, clinical advances may not reach older adults who could benefit the most.

Public health relevance
PROJECT NARRATIVE/RELEVANCE This project will develop novel methods to capture the increasing specialization of physicians in the US based on their observed practice patterns, describe patterns in subspecialization over time and geography, and assess the impact of subspecialization on health outcomes for older adults. The results from this work will provide novel evidence to guide health policy for the aging population, including improved methods to accurately measure specialty supply, evidence to guide health insurers and policymakers for applications such as determining adequacy of specialist coverage in insurance design (e.g., Medicare Advantage), data for identifying populations with shortages in subspecialist access, and evidence for guiding development of telemedicine infrastructure. This understanding will be crucial for policies regarding the growth and distribution of subspecialty expertise and technologies to implement the National Institute on Aging’s mission of improving the health and well-being of older Americans.